LONG TERM EFFECTS OF INTRAUTERINE COCAINE EXPOSURE ON INFANTS

The effect of children being passively exposed to crack smoke after birth through their mother's continued postnatal use is being studied.